Administrative Core

Project Summary/Abstract:
The primary function of the Administrative Core is to ensure the smooth and efficient operation of the Center.
The Core will monitor and evaluate the overall progress and productivity of the Center through scheduled meet-
ings, reports and analysis. Further, the Core will be the primary interface of the Center to the outside community.
It will be the central contact point for all interactions with the funding agency (NIBIB).
The core will be responsible for organizing outreach and for coordinating contact with outside groups, and will
be responsible for maintaining the web presence of the Center. The core will also select, with input from the
External Advisory Committee (EAC), new collaborative, service or training projects, and will coordinate and vet
all such arrangements the Center enters into. It will track the outcome of all training, service, and collaborative
recipients of the Center.
Internally, the Administrative Core will be the contact point between the Center Personnel, the various Center
committees, and the University and ARMI|BioFabUSA administrations. Dr. Caplan will be the PI and Director of
the Center and will be ultimately responsible for the overall administration and direction of the work. Dr. Welter
will be the Associate Director of the Center, will assist Dr. Caplan with day-to-day operations of the Center, and
will liaise with his counterpart, Dr. Bollenbach, (Associate Director for Translation and Manufacturing) at Bio-
FabUSA. The Core will be responsible for administrative tasks, e.g., designating the EAC and other internal
committee members, and coordinating interactions with them. The Core will also handle fiscal duties such as
dispersing funds, authorizing equipment requests, managing cost defrayment from service agreements, and
disbursing travel funds. The Core will also organize all interactions between Case and ARMI|BioFabUSA, includ-
ing routine lab meetings, whether by video conference or in person.
A key function of the Administrative Core will be to provide statistical advice and recommendations, prior, during
and after any experimentation. The statistics component of the Core, led by Dr. Margevicius, will maintain a
database of all the data that are generated through the Center and collaborative/service activities, and will be
responsible for the data-science aspects of the Center.
The Core will handle, through the University Technology Transfer Office, and through the ARMI|BioFabUSA Legal
group, all IP related issues (Invention disclosures, patent applications, MTAs and NDAs). Finally, the Core, pri-
marily through Dr. Welter at Case and Dr. Bollenbach at ARMI|BioFabUSA, will ensure regulatory compliance of
the Center by, e.g., ensuring that grant-reporting requirements are met, and ensuring compliance with all IRB,
IACUC, and IBC regulations as needed, as well as all data and software sharing requirements.